Genomics

Project Summary/Abstract
The GTP provides graduate and postgraduate training and research opportunities at the
University of California, Berkeley, emphasizing the cross-disciplinary nature of this
rapidly advancing field. Accordingly, the 43 training faculty and proposed trainees are
drawn from diverse departments and graduate groups, and is associated with a
campus-wide Designated Emphasis that formalizes the requirements for a broad
education in computational biology and genomics. The program has three principal
thrusts: population and evolutionary genomics, functional genomics, and computational
and statistical methods. Trainees will take advantage of a rich training environment of
seminars, retreats, and group meetings as well as a diverse set of formal course
offerings that range from introductory to advanced methods in genomic biology.
Research training will typically begin by the end of the second year, following an
introductory period of laboratory rotations, coursework, and preliminary examinations.
Progress of the trainees is evaluated by annual thesis reviews and regular meetings
with mentors. The Program will train an average of 10 predoctoral students per year in
genomics and computational biology.

Public health relevance
Project Narrative Genomics is revolutionizing approaches to human health, from the design, analysis, and interpretation of clinical studies to the exploration of the fundamental biology underlying the human condition. Our training program will develop the next generation of genomically literate scientists and engineers.